ONCOGENE ALTERATION IN MICE INDUCED BY CHLOROPRENE

The frozen neoplasms from mice exposed to chloroprene were examined for p53 protein by immunohistochemical method. The neoplasms with positive p53 protein were evaluated by PCR-based assays, including SSCP and direct sequencing analysis. Two second exon CGA mutations were identified, one in H-ras and one in K-ras. No other transforming genes were detected in total 12 multi-site neoplasms. Further molecular mechanistic studies on chloroprene-induced neoplasms in this mouse model may faciliatate understanding potential carcinogenic risks of chloroprene to humans.